Tissue Engineering and Regenerative Medicine Undergraduate Research Addressing Challenges in Kidney and Urologic Diseases

PROJECT SUMMARY
This 5-year Summer Undergraduate Research Institute for Meeting Challenges in Kidney and Urologic Diseases
(KUD) at the Wake Forest Institute for Regenerative Medicine (WFIRM), offers diverse cohorts of 8
undergraduate students each summer (2022-2027) 10-week multidisciplinary research opportunities utilizing
tissue engineering and regenerative medicine (TERM) strategies to address challenges relevant to the
prevention, and treatment of kidney and urologic diseases. With interest in addressing the perseverance of the
“leaky pipeline” negatively impacting the diversity of the biomedical workforce, we focus on participation of
under-represented minority groups, women, and non-traditional students – including students attending
2- and 4- year universities with limited research and first-generation students. Through companion foci of
disparities in KUD research and health care, coupled with research courses for skill development and novel
educational/career persistence interventions to support student participants, we expect to: 1) enhance diverse
students’ participation, learning and mentored research experience with faculty and near-peer graduate mentors
during and beyond the 10-week on-site program; 2) enhance students’ knowledge, career intentions and
persistence in TERM in KUD research, specifically, and careers in biomedical research broadly; 3) develop and
implement a specialized career intentions and perceptions evaluation approach; 4) make a bigger impact on the
community; and 5) increase matriculation into graduate, PhD, and MD/PhD programs and careers with focus in
TERM and KUD research. These goals will be accomplished via a highly coordinated, mentored interdisciplinary
summer research institute with a combination of hands-on and “virtual” research activities, instrumentation
training, didactic components, specialized workshops, seminars and mini courses available across participating
departments and centers and other funded NIDDK R25 programs, spanning bioethics, responsible conduct of
research, health disparities, oral and written communications, and program-tailored education and career
development perceptions and intentions evaluation. All students provide an oral overview of their research,
present scientific posters at the NIDDK Summer Research Symposium and will be provided institutional support
for submitting abstracts for presentation at regional and national conferences. The program incorporates WFIRM
faculty, near-peer graduate students and leverages partnerships with the WFSM Department of Urology, the VT-
WF School of Biomedical Engineering and Sciences and the WFIRM Bladder Research Center. Achieving our
goals will be facilitated by multiple extant regional and national partnerships with scientific, educational and
minority serving institutions to enhance recruitment, professional development and, notably, retain focus on KUD
research priorities. Overall, we expect these activities and approaches will reinforce positive alignment between
self-perceptions, perceptions of scientists, and career intentions and success in TERM and KUD research fields
across academic, government, and industry sectors.

Public health relevance
PROJECT NARRATIVE With priority emphasis on the recruitment and participation of under-represented minority groups, women and non-traditional students, this new summer institute undergraduate research program at the Wake Forest Institute for Regenerative Medicine (WFIRM), will provide 8 undergraduate students each summer (2022-2027) with 10- week summer research opportunities utilizing tissue engineering and regenerative medicine (TERM) strategies to address challenges relevant to the prevention, treatment and, ultimately, cure of kidney and urologic diseases. This broad research experience will be supplemented with extensive mentoring, hands-on instrumentation training, didactic educational experiences, specialized training with workshops on bioethics, responsible conduct of research, health disparities, effective oral and written communication, and program-tailored education and career development perceptions and intentions evaluation interventions. We also include special introductory short courses to familiarize students with the fundamentals of TERM with applications in KUD research and another towards understanding and addressing health disparities in DDKD.